Preclinical/Co-Clinical Section

PROJECT SUMMARY PRECLINICAL/CO-CLINICAL CORE
The primary objective of the JCPG Preclinical/Co-Clinical core is to identify and test novel therapeutics using
patient-specific mouse models that are developed and characterized by the Disease Modeling Unit (DMU). To
achieve this aim, the JCPG Preclinical/Co-Clinical core will serve to nucleate and collaborate with clinical
partners, healthcare professionals, patients, researchers, and foundations, to gather patient samples and clinical
information. This data will be relayed back to our Disease Modeling Core (DMU) to identify the phenotypic and
molecular assays necessary for the characterization of the engineered mouse model and potential incorporation
into future pre-clinical testing, including the discovery of prognostic biomarker data using comparative proteomics
between patients and mouse models. In instances where the mouse models exhibit strong face validity in
phenotyping, we will work both internally and with our extensive network of therapeutic design partners to create
genome-based therapeutics, such as antisense oligonucleotides (ASOs), genome editors, gene replacement
constructs, and siRNAs, all guided by well-defined disease mechanisms. Further, we will explore the potential of
repurposed drugs or novel small molecules as opportunities present. Subsequently, we will conduct both in vitro
screening and in vivo therapeutic evaluations in mice, with the ultimate aim of producing a pre-IND data package
that demonstrates initial safety, efficacy, dose optimization, route of administration, biomarker identification, and
biodistribution data for clinical readiness.